Methods Core

Use continuationpages as neededto provide the requiredinformationin the format shownbelow. Start with Program Director(s)/PrincipalInvestigato'r(s). List all other senior/keypersonnel in alphabetical order, last name first. Name eRA Commons User Name Organization Role on